Metalloenzymes and metal homeostasis

Project Summary/Abstract There have been no changes to the Project Summary/Abstract for the R35 GM118035 parent award.

Public health relevance
Project Narrative There have been no changes to the Project Narrative for the R35 GM118035 parent award.